Environmental arsenic, immunoregulation, and viral disease risk

PROJECT SUMMARY / ABSTRACT
Arsenic exposure from well water and food is a major public health concern and is associated with increased
morbidity and mortality from viral infections. Influenza A virus (IAV) annually infects ~5 million people causing
acute respiratory symptoms and up to 646,000 deaths. The severity of viral disease varies between individuals
and is likely to involve both genetic and environmental effects on immunoregulation. Epidemiological and animal
model studies suggest that early life exposure to arsenic alters the immune response to pathogens, resulting in
prolonged or excessive inflammation. Furthermore, available evidence indicates that arsenic is an endocrine
disruptor that interferes with the glucocorticoid receptor (GR) signaling pathway, a critical regulator of
inflammation, possibly with intergenerational epigenetic effects. However, significant gaps remain in our
understanding of how arsenic disrupts GR signaling and promotes inflammation. This exploratory/ developmental
research project will use zebrafish as a model system to test the novel hypothesis that arsenic exacerbates viral
disease by downregulating the klf9-dependent anti-inflammatory GR signaling pathway. Preliminary studies
indicate that Klf9 is a GR-responsive negative regulator of proinflammatory genes, and that basal and cortisol-
induced klf9 activity is suppressed in zebrafish embryos exposed to very low levels of arsenic. Zebrafish larvae
have a functional innate immune system and are a powerful model to study host-pathogen interactions during
systemic or localized influenza (IAV) infection, as trafficking of macrophages and neutrophils to the site of IAV
infection can be visualized using live imaging with transgenic lines with fluorescently labeled leukocytes as well
as fluorescently labeled viruses. The proposed research will use those tools, as well as GR amd klf9 knockout
lines that we recently created using CRISPR, to accomplish two specific aims. The first is to determine if arsenic
dysregulates the inflammatory response to IAV infection by suppressing the anti-inflammatory GR-Klf9 signaling
pathway, leading to excessive an/or prolonged pro-inflammatory gene expression and failure to resolve the
response. This will be accomplished by asking how treatment of zebrafish larvae with arsenic affects expression
of klf9 and downstream proinflammatory genes that we have identified as putative targets of Klf9-mediated
repression, and assessing the effects of arsenic and klf9 dosage on the response dynamics of inflammatory cells
(neutrophils and macrophages) and NF-kB activity following IAV infection. The second specific aim is to
determine if arsenic exposure has intergenerational effects on the innate immune response to IAV infection that
correlate with aberrant activity of the GR-Klf9 immunoregulatory pathway. To accomplish this, F0 arsenic- or
vehicle-exposed wild-type larvae will be raised to adulthood and inbred through 2 generations without further
exposure. In larvae from each generation (F1 and F2) we will assess immunoregulatory gene expression and
larval survival after IAV infection. The project will elucidate a novel anti-viral immunoregulatory pathway impacted
by arsenic, opening an avenue for future research focused on further elucidating the underlying mechanisms.

Public health relevance
PROJECT NARRATIVE Environmental arsenic is a major public health concern. Early life exposure to arsenic from well water or food increases severity of viral infections later in life, by unknown mechanisms. Arsenic is a known endocrine disruptor that interferes with anti-inflammatory glucocorticoid signaling in ways that are not fully understood. This exploratory/developmental research project will test the novel hypothesis that arsenic exacerbates the immune system’s inflammatory response to viral infection by suppressing klf9-dependent anti-inflammatory glucocorticoid signaling.